Fragile Families Summer Data Training Workshop Series 2021-2025

ABSTRACT
This proposal seeks funds for a series of five summer workshops that will train a diverse group of early-career
scholars on the use of the Fragile Families and Child Wellbeing Study (FFS), a population-based, longitudinal,
NIH-funded birth cohort survey developed to further understanding of the social and behavioral factors
affecting the development of urban children. Compared with children born to married, college-educated
parents, children born to unmarried parents, who lack a college education, often referred to as “fragile
families,” are much more likely to grow up in poor, high crime and violent neighborhoods and to attend schools
with other poor children. Biomedical and population scientists have raised a multitude of questions about the
extent to which such environmental factors affect child and adolescent wellbeing, the extent to which they may
moderate the genetic predispositions of children and adolescents toward health or behavioral challenges, and
the mechanisms that govern any causal effects. The FFS has played an important role in addressing these
questions; however, much remains to be learned, and the collection of new contextual and genetic FFS data
stands to further advance the research literature. As such, the proposed workshops will each focus on a
thematic area relevant to the above-mentioned concerns and will discuss different aspects of the FFS data not
covered in prior training workshops, including adolescent sleep, health behavior relationships; cognitive
development; DNA methylation ; brain development; criminal justice involvement; and outcomes for children
when they are 22 years old. The proposed series of workshops will train a new generation of researchers from
a variety of disciplines in the social and biomedical sciences on the capabilities of the FFS data and will result
in the dissemination of the Fragile Families data, an improved understanding of the issues facing adolescents
and young adults in fragile families, and opportunities for mentorship and collaboration for a new generation of
social, behavioral, and biomedical scientists.

Public health relevance
PROJECT NARRATIVE This proposal seeks funds to develop and operate a 5-year series of summer workshops to train a diverse group of early-career scholars on the use of data from the Fragile Families and Child Wellbeing Study. The workshops will present substantive findings from the data, discuss the measurement of key constructs for population research, and provide hands-on training with the Fragile Families data. In so doing, the proposed workshop will support a cohort of emerging scholars and further the understanding of behavioral and social functioning relevant to the health and wellbeing of adolescents and families.